Timeliness of Symptom Recognition, Interpretation, and Reporting in Heart Failure

PROJECT SUMMARY (See instructions): This K99/R00 award will provide mentored research experiences for Dr. Reeder to achieve success as an independent investigator. Dr. Reeder's program of research is aimed at improving self-management and clinical care outcomes of patients with cardiovascular disease, the nation's number-one killer. K99/R00 mentored research activities will support 1) implementation of a clinical research study to explore how adult patients living with heart failure (HF) recognize, interpret, and report symptoms; 2) verification of the content and construct validity of a theoretical and clinically-based interview questionnaire on HF symptom recognition, interpretation, and reporting using novel Bayesian analyses; 3) advancement of knowledge about self-management of HF; and 4) development a research proposal to examine empirically the effect of an evidence-based intervention informed by findings from this K99/R00 study. Proposed educational activities will provide Dr. Reeder with new knowledge integral to developing an independent program of research to improve outcomes for people living with cardiovascular diseases. During the ROO phase. Dr. Reeder will apply this knowledge, conducting an independent secondary analysis, using her K99 questionnaire data merged with longitudinal data from her mentor's NHLBI HF clinical trial. Building on her dissertation that evaluated the influences of social interactions on pre-hospital delay in acute myocardial infarction, Dr. Reeder wiil use an exploratory descriptive design to investigate symptom recognition, interpretation, and reporting by employing both the innovative Day Reconstruction Method for data collection and novel Bayesian analysis. The ultimate goal is an independent program of research to promote effective self-management of cardiovascular diseases, enhance quality of care, and reduce costs.

Public health relevance
Understanding how people recognize, interpret, and report health changes and symptoms can help health care providers identify ways improve heart failure status and effectively avoid untimely, repeated heart failure hospitalizations.